PERSONALITY DISORDERS IN THE AGING

The objective of this Clinical Mental Health Academic Award application is to assist Dr. Robert Abrams in his academic activities in the field of geriatric psychiatry and to develop a clinical research program in geriatric personality disorders at the New York Hospital-Westchester Division. The award will free Dr. Abrams from most of his present clinical responsibilities and permit him to: 1) Develop as an expert in assessment and interpretation of personality disorders and symptoms in geriatric patients; 2) study the principal methodological problems that have limited research in this field up to the present time; 3) generate new instrumentation to evaluate personality traits and disorders in cognitively impaired elderly subjects; and 4) conduct a research project studying personality disorder symptomatology as predictors of outcome in geriatric Major Depression. As a result of these efforts, hypotheses on underlying relationships of personality traits, aging, and affective disorders will be formulated.